MOLECULAR CONTROL OF CALCIUM INFLUX AT THE ER-PLASMA MEMBRANE JUNCTIONS

Project Summary / Abstract.
Store-operated calcium entry (SOCE) constitutes a major calcium entry pathway in mammals to control
lymphocyte activation, muscle contraction, gene expression and cell metabolism. The calcium release-
activated calcium (CRAC) channel composed of ORAI-STIM represents a prototypical example of SOCE in
lymphocytes. The clinical relevance of SOCE is exemplified by two human diseases, the severe combined
immunodeficiency (SCID) and tubular aggregate myopathy (TAM), which are caused by loss- or gain-of-function
mutations in ORAI1 and STIM1, respectively. Augmented SOCE is also implicated in cardiovascular disorders
and cancer metastasis. Therefore, CRAC channel has been pursued as an attractive drug target for therapeutic
intervention. Tremendous efforts have been directed to establish ORAI-STIM as the minimal two-component
system to couple ER calcium store depletion with calcium influx across the plasma membrane. The regulatory
machinery dedicated to the ORAI-STIM signaling, nonetheless, still remains incompletely defined.
In this proposal, the PI aims to bridge this critical knowledge gap by unveiling the functions of two novel
SOCE modulators, which reside at distinct subcellular locations to act on different steps of ORAI-STIM
signaling: the initial activation of STIM within the ER lumen and the later stabilization of ORAI-STIM complexes
at ER-PM membrane contact sites (MCS), where the close appositions of two membranes are separated by a
gap distance of 10-30 nm. In Aim 1, based on preliminary findings from proteomic profiling of potential STIM1
interactors within the ER lumen, the PI will define how a previously-unrecognized multiple EF-hand protein
cooperates with the luminal domain of STIM1 (EFSAM) to shape the activation and deactivation kinetics of
SOCE. The PI will employ a new “ER-to-PM” trafficking strategy to expose the luminal domain toward the
extracellular side, thereby overcoming a major impediment to studies on the liminal sides of ER-resident
signaling proteins. In Aim 2, capitalizing on the discovery of a TMEM family protein as a regulator of calcium
influx at ER-PM MCS, the PI will define how this modulator responds to physiological stimuli to remodel the
assembly of ER-PM junctions and PIP homeostasis to sustain SOCE. The generation of innovative optogenetic
tools and a transgenic mouse model to dissect calcium signaling and protein-PIP interactions will further
accelerate our structure-function relationship studies on these novel regulators.
Overall, the new mechanistic insights gained through the proposed study will lead to advances in the
constantly-revitalized field of calcium signaling, and in parallel, spawn the vibrant field of membrane contact
sites. In the long run, discoveries made in the study can be translated into the development of effective
therapeutics targeting aberrant calcium and phosphoinositide signaling.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) The proposed research is directly relevant to public health and the NIH’s mission of developing fundamental knowledge that will help to reduce the burdens of human disability. The overall goal of this project is to unravel the molecular controlling and regulatory mechanisms of store- operated calcium entry, an indispensable pathway that constitutes the primary calcium entry route in human cells. Dysregulated calcium entry is directly linked to pathological conditions such as immunodeficiency, muscle dysfunction, and cancer metastasis; thus, targeting aberrant calcium signaling holds great therapeutic potential for the treatment of these human disorders. ! !